EFFECT OF FOUR DRUG/DOUBLE PROTEASE INHIBITOR THERAPY IN HIV PATIENTS

To determine the efficacy of a four drug regimen containing two protease inhibitors, Saquinavir Soft Gel Capsule and Nelfinavir, plus two reverse transcriptase inhibitor on the complete suppression of HIV-1 viral replication in antiretroviral naive patients and as a salvage regimen in Indinavir experience patients. To determine how compliance nad measures of drug exposure influence the response to therapy, and to understand possible mechanisms of therapeutic failure.